The Role of Estrogen Receptor Alpha Variant Size and Localization in Modulating TLR7-Induced Inflammation

Systemic lupus erythematosus (SLE) is one of many autoimmune diseases that disproportionately affects
females. Although many risk factors for lupus are identified: >170 genes including GPR174, myriad
environmental exposures, and aberrant X chromosome inactivation, none of these sufficiently explain the steep
rise in incidence of ADs at the time of puberty in a female-specific manner. Epidemiology suggests a major role
for sex hormones and their receptors in autoimmune diseases. We previously showed that female lupus-prone
mice, expressing only a short form of estrogen receptor alpha (ERα short), have significantly reduced renal
disease and increased survival. Determining the mechanism of this protective effect, which is estrogen
dependent, is the primary goal of this proposal. Of note, ERα-/- (null) lupus prone mice were not similarly
protected. Combined, our data suggest that the presence of the short form of ERα confers protection, not the
absence of full-length ERα. Others and we demonstrated a critical role for ERα in dendritic cell (DC) development
and endosomal Toll-like receptor (TLR) responsiveness. Interestingly, the ERα expressed in ERα short mice is
similar in structure to an endogenous ERα variant (ERα46) that lacks the same AF-1 domain, and differentially
regulates gene transcription compared to full length ERα. Overexpressing ERα46 in vitro also modulates TLR-
induced responses, relevant to this proposal. In the proposed study, we will further investigate the role of ERα
short variants in modulating TLR7-induced immune responses, and determine whether genomic and/or non-
genomic mechanisms of ERα short variant action are protective. Our overall hypothesis is that increasing
expression of ERα short or ERα46 in immune cells will be anti-inflammatory, and that the ratio of ERα46
to ERα66 is decreased in lupus patients versus healthy controls. We also hypothesize that targeting
immune cells with novel anti-inflammatory selective estrogen receptor modulators (SERMs) that alter ERα
membrane signaling and/or ERα-induced transcription will uncouple estrogen-mediated anti-inflammatory
responses from those impacting reproductive tissues. We will test our hypotheses by accomplishing these
Specific Aims: 1) Overexpress ERα short or treat immune cells with novel SERMs (OBHS, PaPE) that select for
anti-inflammatory properties of ERα and determine the effect on known TLR7-induced inflammatory endpoints,
2) Investigate effects of membrane-only ERα signaling vs. nuclear only ERα expression on TLR7-induced
pathways in mice, and 3) Identify ERα variants in human monocyte-derived dendritic cells (mo-DCs) and B cells
using droplet digital PCR and Iso-Seq technology, to determine whether ERα46 is differentially expressed in
lupus patients vs. controls, potentially explaining a biologic difference in females predisposed to autoimmunity.
These aims will allow us to determine if we can separate ERα's reproductive effects from its potentially modifiable
immune effects as a therapeutic strategy, which if successful, will provide novel approaches to immune
modulation in lupus and other immune mediated diseases, especially those with a significant sex bias.

Public health relevance
Most autoimmune diseases have a profound sex bias, affecting females of reproductive age 3-16:1 over males, and the precise cause of this bias remains unknown. We hypothesize that a short variant of estrogen receptor alpha (ERα), akin to an endogenous ERα variant, is important for anti-inflammatory effects of estrogen in innate immune cells and is targetable. This hypothesis will be tested by varying levels of ERα variants, by selecting ERα cellular location as well as using novel anti-inflammatory selective estrogen receptor modulators (SERMs) that may prove useful as adjunctive treatment for autoimmune diseases such as lupus.